2/4 Powering Genetic Discovery for Severe Mental Illness in Latin American and African Ancestries

Project Summary
Genetic discovery for schizophrenia and bipolar disorder lags behind that in other areas of medicine, where the
identification of mutations responsible for familial forms of major disorders has yielded extraordinary biological
insights. However, recent successes in gene identification from both rare and common variant analyses indicate
what the field needs to do to catch up: expand the size, diversity and scope of genetic studies. Indeed, NIMH
recognized this need, issuing PAR-20-027, “Genetic Architecture of Mental Disorders in Ancestrally Diverse
Populations.” In response to this call, we will create the Populations Underrepresented in Mental illness
Association Studies (PUMAS) Project, an international collaboration of investigators from the US, South America
and Africa with the strongest track record of large-scale psychiatric genetic research in Latino and African
populations, along with several of the field’s leaders in genetic data generation and analysis. PUMAS will be well
powered to discover new genes for schizophrenia and bipolar; it will dramatically increase the diversity of genetic
discovery efforts, an important step towards reducing health disparities; and it will expand the scope of psychiatric
genomics by generating low-pass whole genome sequencing for 120,000 samples (which we will analyze
together with 22,500 samples already sequenced by our team). Through these efforts we will also discover
similarities and differences in genetic architecture of schizophrenia and bipolar across diverse ancestries and
environments. The Aims of the PUMAS project are to: 1) Build the PUMAS sample bank of schizophrenia cases,
bipolar cases and controls from Africa and from admixed populations in the Americas, achieving a total sample
of 183,500 (88,600 cases and 94,900 matched population controls) by recruiting 17,000 new cases and 16,500
controls. 2) Generate low-pass whole genome sequencing (WGS) data and variant calls on 40,000 cases of
schizophrenia, 40,000 cases of bipolar disorder and 40,000 matched controls from African, Native American and
admixed ancestries b) perform extensive sample and variant quality control. 3) a) Systematically analyze the
combined dataset to power discovery of the genetic basis of schizophrenia and bipolar across diverse ancestries
and down the allele frequency spectrum; and b) through portals and browsers, share the data and results of the
genetic studies with the world. The PUMAS 120,000 sample WGS dataset, together with data for 22,500
previously sequenced admixed (AA+EA) samples, provides sufficient statistical power for genetic discovery for
SZ, BP, and combined across diverse ancestries. Our study will identify new genes and loci, increase the
precision of fine-mapping of known loci, and form the foundational knowledge base for polygenic risk scores
(PRS) of global value.

Public health relevance
Project Narrative The Populations Underrepresented in Mental illness Association Studies (PUMAS) Project will collect samples from 17,000 individuals with severe mental illness from across African and the Americas to create a total sample dataset of 183,000 from across Africa and the Americas. We will generate and analyze whole genome sequencing data on 40,000 schizophrenia patients, 40,000 bipolar patients and 40,000 controls to learn the similarities and differences of the genetic architecture of severe mental illness across diverse ancestries and environments.